Vaccine and Treatment Evaluation Units (VTEU) 24-0003

BAYLOR COLLEGE OF MEDICINE- ABSTRACT
The purpose of this Phase 4 study is to compare strategies for prevention of RSV lower
respiratory tract disease infection in infants in a single study. Both maternal vaccination with
RSVpreF and passive immunization of infant with monoclonal antibody at birth are
recommended. Sequential administration of both products for some infants may be indicated
but this has not been studied. This study will evaluate the safety and immunogenicity of 4
prevention strategies using these approved products. It is expected that the results of this study
will policy recommendations and clinical decision-making for pregnant women and their infants.

Public health relevance
BAYLOR COLLEGE OF MEDICINE- NARRATIVE This is a prospective, randomized, open-label Phase 4 study of the safety and serology of maternal RSV vaccination (ABRYSVOTM), infant nirsevimab (BEYFORTUSTM) immunization (both of which are approved strategies), or both products during the first year of life.